Disrupting Protein-Protein Interactions with Self-Assembling Macrocycles

PROJECT SUMMARY
The long-term objective is to understand the chemistry of a new class of ring-shaped (macrocyclic)
molecules and the potential that these molecules might have in modulating interactions between proteins.
Controlling protein-protein interactions is an under-explored area of research and is fertile ground for the
discovery of new drug leads and strategies. Academic labs, biotech companies and big pharma are investing
increasing energies into these pursuits.
Preparing rings represents a synthetic challenge that rarely has a general solution. That is, while many
methods have been used successfully, they can be limited in scope or substrate specificity. Dynamic
covalent chemistry is a powerful alternative to traditional synthesis, but commonly, the result is a mixture
of products.
Fortuitously, simple chemistries have been discovered to make molecules in 2 steps that spontaneously
dimerize to yield a single macrocyclic product in quantitative yield. The backbone of these molecules
offers numerous sites for manipulation. Groups that could affect selectivity and affinity of the macrocycle
toward a protein target can be incorporated and the size of the ring can be changed.
The proposed efforts focus on three general aims. The first two aims are chemical. Having established the
generality of the motif over the last period, the affect that substitution has on shape, the critical element of
drug design, will be probed. Shape influences affinity, solubility and important parameters like logP which
predicts whether a molecule crosses membranes. The current studies are extended to larger rings that adopt
protein-like shapes (beta-sheets). These efforts will be executed in the lab of the PI using primarily
undergraduates. The third aim is biological. The collaborating co-I works on breast cancer. Protein-protein
interactions between BRCA1 and PALB2 (breast cancer gene products) are explored with truncated models
that recapitulate the native system. The ability of the proposed macrocycles to modulate interactions
between these proteins will be assessed.

Public health relevance
PROJECT NARRATIVE This proposal investigates a largely unexplored strategy for treating disease. A new class of ring- shaped molecules called macrocycles will be studied because they could potentially the leads for new drugs. These molecules are designed to disrupt the interactions between proteins. While controlling specific protein-protein interactions with specific macrocycles could lead to treatments for many different diseases, this work focuses on disrupting protein-protein interactions in breast cancer.